Building a somatosensory atlas for interoception

Project Summary/Abstract
Somatosensory neurons are well-known for innervating skin and muscle and transmitting sensations such as
touch, pain, itch, and proprioception to the brain. However, these same type of heterogeneous set of neurons
also innervate internal organs and are responsible to convey information of the internal state of our body. These
interoceptive signals include both conscious (bladder fullness) and subconscious (blood pressure) senses.
Despite their importance, we do not know their projection patterns and physiological roles. Here, we propose to
use a set of innovative tools that will allow us to specifically label, visualize, and isolate sensory neurons
innervating various internal organs. Using a variety of state-of-art molecular, imaging, and genomic techniques,
we will build an anatomical database of these neurons and use snRNAseq to establish the molecular identities
of individual sensory neurons based on their innervating organs. Finally, the anatomical, cellular, and molecular
maps will be standardized, indexed, and integrated into an atlas that will allow the community to freely access
the data.

Public health relevance
NARRATIVE Many internal organs communicate with the brain via hormones; however, these organs are also innervated by sensory neurons, but the role of these interoceptive neurons have remained unknown. In this proposal we will utilize various innovative molecular, imaging, and genomic tools to establish an atlas of sensory neurons innervating various organs to begin to understand the role of interoceptive neurons in physiology and pathology.